Ubiquitin‐mediated proteolysis and cell cycle control

PROJECT SUMMARY
CULLIN-RING E3 ubiquitin ligases (CRLs) employ ~200 adaptor proteins to bind and ubiquitylate substrates,
and their dynamic assembly with adaptor proteins is regulated by the neddylation cycle together with the
CAND adaptor exchange factor. Several CRLs have been linked with turnover of proteins involved in aging,
cell cycle control, DNA repair, transcription, and cellular signaling pathways. Despite these advances, our
understanding of the CRL system is incomplete for several reasons. First, the majority of studies on CRLs
have focused on the functions of a small number of well-studied adaptors. As such, we have a limited
understanding of the targets and biological functions for a substantial portion of the CRL system. Second, the
many studies have been performed in cancer cell lines, leaving open the roles of these proteins in a more
physiological setting. Third, many adaptors likely have multiple substrates and function through structurally
related degrons in diverse substrates, yet we do not understand the biochemistry of degron targeting for the
majority of adaptors. Such information can broadly inform discovery of biological functions, as has been the
case for a small number of CRL adaptors such as TRCP. To bridge these knowledge gaps, our work has
focused on the development of genetic methods to rapidly identify CRL adaptor targets and cognate degron
sequences in substrates, and on the development of proteomic approaches that allow global quantification of
proteome remodeling in response to cellular, genetic, or chemical cues. In AIM 1, we build on our discovery of
10 N/C-End E3 ubiquitin ligases that recognize their targets based on sequences at their N or C-termini to
systematically elucidate their targets and roles in proteome remodeling as cells undergo differentiation to germ
cell lineages. Human stem cell differentiation to germ cell lineages is associated with alterations in the
abundance of >30% of the proteome, and we propose that N/C-End E3s play a central role in proteome
remodeling, in part via quality control dependent protein degradation. This aim also builds on our extensive
characterization of CRLs in this system, and on the development of multiple proteomic methods that provide a
quantitative understanding of protein turnover and remodeling during changes in cell state. In AIMs 2 and 3, we
further develop an experimental platform for genetic discovery of CRL targets and degrons (including regulated
phosphodegrons), as well as matching of substrates and degrons with specific CRL adaptors. We provide
examples of how these two platforms have resulted in the mechanistic dissection of new pathways for turnover
of key transcription factors involved in nutrient signaling and propose to analyze newly discovered substrate-E3
pairs using systematic biochemical and cell biological approaches. Our expectation is that these studies will
substantially advance our understanding of the molecular determinants in CRL dependent protein degradation
and will provide unique insights into mechanisms underlying proteome remodeling during changes in cell state.

Public health relevance
PROJECT NARRATIVE CULLIN-RING E3 ubiquitin ligases (CRLs) represent the largest class of ubiquitin ligases and use more than 200 adaptor proteins to specific substrates. However, numerous gaps exist in our understanding of what determines the identity of targets of CRLs. We will employ powerful genetic and biochemical methods to reveal the architecture of the CRL system, including the identification of dozens of E3-target pairs and will elucidate how one subfamily of CRLs controls proteome remodeling during conversion of human ES cells to germ cell lineages